Neural Correlates of Location-Specific Contextual Threat Discrimination in Post-Traumatic Stress Disorders REV1

Posttraumatic stress disorder (PTSD) is a highly prevalent and debilitating disorder. Despite efforts to
characterize the pathophysiology of PTSD, no measurable indicators have been established to aid in diagnosis,
treatment development, and prediction of treatment response. This K01 presents a program for research and
training that will support the applicant on a path towards becoming an independent investigator, focused on the
underlying neural mechanisms of learning valence discrimination within an environment using location-specific
information through an interdisciplinary approach. The training plan builds on the candidate’s prior training and
experience and capitalizes on a mentorship team and a research environment to foster development of the
candidate’s expertise in 1) the understanding of neural and psychophysiological profiles related to PTSD, 2)
gaining deeper proficiency in multimodal magnetic resonance imaging (MRI) data acquisition and analysis, 3)
the understanding of mental disorder symptomatology and diagnosis & expertise in patient-related research, and
4) responsible conduct in scientific research. This research project will use a novel virtual reality task, created
by the applicant and validated in healthy humans, to assess brain activity differences between patients with
PTSD (n=30), trauma-exposed healthy controls (TEHC, n=30), and no trauma-exposed health controls (HC,
n=30). A multimodal MRI approach (functional, resting-state, and structural MRI), will be used aiming to clarify
the neural mechanisms underlying contextual threat discrimination in PTSD. Also, the fMRI will be coupled with
peripheral measures of anxiety (e.g., skin conductance response, heart rate, breathing, pupillometry), subjective
ratings of anxiety, and symptom clusters of PTSD. This research will be conducted at the University of Rochester,
an optimal location due to the hospital and access to patients with PTSD, and imaging facilities. The results of
the proposed research will be vital to clarify the process of discrimination of contextual threat in patients afflicted
by anxiety disorders and PTSD and will lead to future R01 grants examining other threat-related learning
processes across anxiety and trauma-related disorders. Together, the research and training experiences and
expertise developed through this K01 award will support the applicant’s transition to research independence and
ensure the applicant becomes a leading authority in the specific role of brain areas needed for threat learning
and discrimination within an environment and how they break down in mental disorders.

Public health relevance
PTSD can occur after a direct or indirect traumatic experience and is a highly prevalent and debilitating disorder. This research project adds a new virtual reality paradigm specifically design to study context discrimination within a single environment. In the long term, this research will shed light on deficits of specific brain areas and neural circuits during threat learning and discrimination within an environment in PTSD, which will advance the development of effective diagnostics and treatments for PTSD.